Cell Signaling and Cell Decisions

PROJECT SUMMARY/ABSTRACT
Human cells integrate external and internal signaling inputs to make regulatory decisions that change
functional outputs. Two such decisions of cells – the decision to polarize and migrate and the decision to enter
the proliferative state - are central to multicellular development and tissue maintenance. The regulatory
feedbacks and the core switch mechanisms of how cells start to migrate or proliferate are not yet understood.
Due to significant cell-to-cell variability and lack of synchronization, an understanding of the underlying
regulatory motifs cannot be achieved by biochemical and genetic approaches alone. However, recently
developed activity reporters and rapid perturbation strategies have made it possible to investigate complex
spatial and temporal signaling feedback architectures and decision processes in living single cells, an
approach that can reveal feedback mechanisms and circumvent the technical bulk assay issues. Our work
seeks to understand the principles of cellular decision processes in human cells by employing these live-cell
methods to monitor, perturb and automatically analyze the relevant signaling processes and ultimately derive
quantitative models of how specific decisions are made.
Our proposed work has Two Themes: In our first theme, we determine how cells initiate and establish
cell polarity and how already polarized cells steer their front during directed migration and chemotaxis. We
have developed automated fluorescence microscopy methods to monitor and perturb the critical Rho family
small GTPases and relevant second messengers, and developed methods to quantify changes in different
actin structures. These approaches will allow us to understand the core regulatory mechanisms for cell
polarization and cell steering during migration. In our second theme, we seek to understand how cells decide
to transition from a quiescent to a proliferative state by investigating molecular mechanisms of competition
between stress and mitogens, by determining the molecular mechanism of the point-of-no return for cell cycle
entry, and by exploring how sequential signaling events prevent the re-replication of the same DNA to ensure
that DNA is only replicated once. We have developed a number of live cell cycle activity reporters, perturbation
strategies and automated single-cell analysis methods that will help us understand and model the regulatory
mechanisms controlling human cell cycle entry.
Both our themes will lead to new concepts of the logics of human decision processes and will provide
detailed molecular and mechanistic models explaining how cells integrate signaling inputs to start to migrate or
enter the cell cycle. Finally, the universal dysregulation of cell proliferation and migration in cancer, and the
frequent dysregulation of these processes in degenerative, immune and other diseases, argues that a
molecular understanding of the complex regulatory architecture of cell migration and proliferation may lead to
new therapeutic strategies for the treatment of a broad range of diseases.

Public health relevance
Narrative The long term goal of the proposed work is to understand the signaling systems architecture that allows mammalian cells to make robust decisions. Specifically, the work will elucidate how cells decide whether or not to proliferate and how stationary cells decide to polarize and migrate. Understanding the relevant signaling mechanism that drive these fundamental decision processes is important to identify new types of therapeutic strategies for cancer and degenerative diseases. !